Visual Stimuli for Selective Modulation of Neural Pathways in the Retina

PROJECT SUMMARY / ABSTRACT
The primate retina’s output is split into 15-20 Retinal Ganglion Cell (RGC) types, each processing and
transmitting different aspects of the visual world. Different RGC types are thought to have distinct roles in
visual processing and behavior, and type selective impairment is implicated in optic neuropathies and
developmental disorders. The response properties of numerically dominant RGC types have been described
using predominantly linear models, and a large body of psychophysical work uses these models to propose
visual stimuli that can selectively drive a given RGC type. However, these stimuli face three important
limitations: 1. Recent studies challenge the accuracy of key model assumptions, 2. They lack direct neural
population testing and the underlying models focus on single cells, and 3. They are predominantly simple
artificial stimuli and the underlying models fail to capture responses to naturalistic stimuli. A lack of validated,
ethologically relevant RGC type selective stimuli limits the ability to answer key questions in visual
neuroscience such as whether Midget RGCs dominate ventral stream processing and Parasol RGCs dominate
dorsal stream processing.
The central aim of this proposal is to acquire the necessary training in sensory neuroscience, psychophysics,
and computational neuroscience to directly test existing approaches, refine and evaluate new models of RGC
responses, and leverage new models to generate effective, ethologically relevant RGC type selective stimuli.
Preliminary data from in vitro population recordings of peripheral Macaque retina suggest that stimuli based on
assumed contrast gain differences between Parasol and Midget RGC types fail to achieve their proposed
selectivity. I will confirm and extend this to other stimuli based on assumed response property differences
between RGC types, which will aid interpretation of behavioral results in healthy and diseased subjects tested
with these stimuli. Further, I will refine and evaluate newer mechanistic and deep neural network models of
RGC responses that can capture nonlinear circuit components driving responses to naturalistic stimuli. I will
leverage these models for precise manipulation of RGC population outputs by systematically generating stimuli
that minimize modulation of one RGC type population while maximizing modulation of others. This will provide
validated tools for studying the downstream contributions of the numerically dominant RGC types in naturalistic
contexts with applications in basic research and the clinic. Through this training and research plan, I will
develop the necessary expertise and skills for contributing substantially to sensory neurophysiology and
pathology as a physician scientist.

Public health relevance
PROJECT NARRATIVE The primate retina’s output is split into several retinal ganglion cell (RGC) types whose differential contributions to downstream visual processing and behavior remain poorly understood due to a lack of validated RGC type selective stimuli. The current proposal will provide the first direct population tests of existing stimuli that rely on flawed older models of RGC encoding, refine newer mechanistic and deep neural network models of RGC encoding, and leverage newer models to produce ethologically relevant RGC type selective stimuli. Completion of this work will provide validated noninvasive tools for probing the contributions of different RGC types to the visual system and aid the development of diagnostic and prognostic tools for RGC type selective diseases.